A whole animal model for investigation of ingested nanoplastic mixtures and effects on genomic integrity and health

Project Summary/Abstract
Microplastics (MP, plastic particles < 5 mm) are pervasive in the environment and an emerging health
concern. MPs have the ability to accumulate chemical pollutants from the environment and contribute to
bioaccumulation of pollutants, making their consumption potentially hazardous. MPs have been found in nearly
all human tissue and specifically, nanoplastics (NPs, ≤ 1 µm) are of alarming concern due to the ability to enter
mammalian cells. Current research into the physiological or pathological effects of nanoplastic pollutant exposure
is limited, and the human risks of ingestion of NPs alone or combined with environmental chemicals are unknown.
The long-term goal is to understand the impact of NP exposure on biological systems. The overall objectives in
this application are to (i) establish Caenorhabditis elegans (C. elegans) as a novel model system for NP-chemical
mixture research and (ii) to test the ability and impact of NPs as a delivery vehicle for environmental chemicals.
The central hypothesis is that NPs, which have absorbed environmental chemicals, will promote DNA damage
and subsequent changes in physiology. The rationale for this project is that chemical pollutants like pesticides
and phthalates are genotoxic and become concentrated in nanoplastics in the environment. Furthermore, model
organisms such as C. elegans can consume NPs and the chemicals contained in them are absorbed by the
animal. Two specific aims are proposed to test the central hypothesis: 1) Determine DNA damaging effects of
NPs and absorbed environmental chemicals and 2) Determine the physiological consequence of NPs and
absorbed environmental chemical exposure. Under the first aim, protocols will be established to quantify
chemical absorption in NPs, and to verify absorption and metabolism of ingested chemicals in C. elegans.
Additionally, we will evaluate DNA damage induced by NP-chemical mixtures by assessing frequency and
location of mutations using an established fluorescent-based reporter. For the second aim, C. elegans exposed
to NP-chemical mixtures will be observed for known physiological defects due to the NPs and chemicals alone,
with the hypothesis that combined effects will be more severe. Furthermore, we will correlate the presence of
DNA damage in specific tissues, with the observed phenotypic changes after NP-chemical exposure. The
research proposed in this application is innovative, in the applicant’s option, because it focuses on systematic
and rigorous methods to assess and determine the combined effects of NP and environmental chemical
toxicology on the cellular level in vivo and in a whole animal, a system that is currently not available. The
proposed research is significant because it is expected to provide strong scientific justification for continued
studies to prevent negative health outcomes due to NP-chemical mixture exposure and will inform exposure
limits on nanoplastics and environmental chemical pollutants. Ultimately such knowledge has the potential to
greatly add to our understanding of the additive toxicology of NPs and environmental chemicals and their risks
to human health.

Public health relevance
Project Narrative Plastic and chemical pollutants are pervasive in the environment and an emerging human health concern. The proposed research is relevant to public health because it will establish a novel model system to rigorously and reproducibly study exposure to nanoplastic and environmentally relevant chemical pollutant mixtures. Once such strategies are developed, there is a potential for significant advancement in understanding the cellular and molecular basis of combined nanoplastic-chemical mixture impact on physiology and thus possible risks to human health.